Combined Regenerative and Rehabilitation Therapies for Extremity Trauma

Description: Extremity trauma has been the predominant cause of combat casualties for U.S. armed forces
members in recent military conflicts. These injuries often result in long-term functional disabilities, pain, and
neurologic dysfunction. This proposal will utilize preclinical models of extremity trauma and test new tissue
engineered therapies in combination with rehabilitation regimens. The overall objective of the proposed study
is to establish an integrated regenerative medicine and rehabilitation therapy treatment protocol to enhance
restoration of limb function following severe extremity trauma. The hypothesis is that treatment of large volume
multi-tissue injuries with regenerative engineering strategies that improve revascularization in combination with
low intensity rehabilitation regimens will enhance tissue regeneration, integration, and long term functional
outcomes.
Research Plan: We propose the following Aims: Aim 1: Engineer regenerative muscle constructs using muscle
stem (satellite) cells and microvascular fragments for Volumetric Muscle Loss (VML) injuries; Aim 2: In a VML
model alone, determine if treadmill running rehabilitation enhances the regeneration of large muscle loss treated
with muscle stem cell constructs; Aim 3: In a multi-tissue extremity trauma model, assess the efficacy of
combined treadmill running rehabilitation and regenerative therapies on muscle and bone healing
Methods: We will use preclinical models of extremity trauma, including VML and multi-tissue bone and muscle
defects. In Aim 1 VML injuries will be treated with regenerative muscle therapies including muscle stem cells or
microvascular fragments which will be delivered in collagen hydrogels or decellularized muscle matrices. In Aim
2, treadmill based exercise will be used to test the role of key rehabilitation parameters including timing of
initiation and intensity on graft integration and function. In Aim 3, rehabilitation and regenerative therapies (as
determined in Aim 2 for re-vascularization potency or muscle regeneration potency) will be tested in a multi-
tissue injury model of composite bone and muscle trauma. Outcome measures will include assessments of
muscle and limb structure and function (Aim 1-3) and bone structure and function (Aim 3).
We anticipate the proposed work will result in new insights on rehabilitation protocols for severely injured limbs
and will be communicated through publications and our clinical consultants to impact military and veterans care.

Public health relevance
Extremity trauma has been a significant combat casualty for military personnel, comprising 58% to 88% of combat wounds, in recent US armed conflicts. These injuries often result in long term functional disabilities and predispose soldiers to chronic pathologies like post-traumatic osteoarthritis. As such, these injuries are a large burden for military personnel, their families, and the whole of the DOD and VA systems. The proposed work will develop new regenerative engineering interventions in combination with rehabilitation therapies that will improve long term functional outcomes for patients after multi-tissue trauma. The outcomes from this work will provide scientific rationale into how quickly the patient can begin to use the limb, how much load to support, and how to implement physical therapy protocols. This information will be disseminated through publications and direct consultation with physical therapist at the Center for the Intrepid and Atlanta VAMC—resulting in improved daily function and ultimately the quality of life of service members, veterans, and their families.